Postdoctoral Research in Neurodevelopmental Disorders

Project Summary
This application, “Postdoctoral Research in Neurodevelopmental Disorders,” is a request for five years of
funding to continue a National Research Service Award (NRSA) Institutional Training Grant (T32). Advances in
behavioral science, neuroscience, and molecular genetics have led to dramatic gains in our understanding of
the pathogenesis of neurodevelopmental disorders. The proposed training program will develop researchers
with dual expertise in the biological basis and clinical manifestations of neurodevelopmental disorders (NDDs).
This broad-based, integrated perspective will enable trainees to develop cross-disciplinary research
perspectives that will maximize their ability to make transformative advances in understanding the
pathogenesis of NDDs and developing effective treatments. Ultimately, this training will prepare researchers to
span disciplines and to use their broad perspective to address the health-related research needs of the nation
– the primary objective of the T32 program.
The proposed training plan provides a variety of opportunities including: (1) mentored research training in
specific methods, disorders, and underlying pathogenetic mechanisms; (2) a range of didactic experiences
(including courses, seminars, and lectures) that integrate the study of clinical disorders, normal developmental
processes, mechanisms of disease, and research methods; (3) clinical exposures to complement previous
basic science knowledge, and basic science exposure to complement clinical experiences; and (4)
appreciation and contribution to improving equity and inclusion in neurodevelopmental disorders research, with
the further goal of instilling diversity outreach as a career value. Fifteen Ph.D. or M.D. level trainees (three new
trainees per year) will participate in this two-year training program, over the five-year period of this proposal.
This proposal addresses the critical need for focused training opportunities beyond formal graduate programs
by using the existing interdisciplinary research and administrative structure of the Carolina Institute for
Developmental Disabilities (CIDD). All faculty mentors are members of the CIDD NICHD-funded Intellectual
and Developmental Disabilities Research Center (IDDRC). The CIDD is a comprehensive program for
services, education, and research in developmental disabilities. Together with the excellent clinical and basic
science resources of the University of North Carolina (UNC), the CIDD provides an ideal environment for
integrating training in biological and behavioral research in NDDs.

Public health relevance
Narrative Individuals with neurodevelopmental disorders, such as autism, intellectual disability, and fetal alcohol syndrome, often have severe impairments that require lifelong care, resulting in a substantial burden to affected individuals, their families, and their communities. The complexity of these conditions demands an integrated strategy that cuts across traditional research boundaries between the behavioral and basic biological sciences, including the boundaries between animal and human studies, as well as the boundaries between the laboratory and real-world applications. In this postdoctoral research training program in neurodevelopmental disorders, we propose an integrated, interdisciplinary training program that will prepare researchers to interface across disciplines and to make transformative advances for the betterment of individuals with neurodevelopmental disorders.